Persistent STAT5 signaling in polyfunctional CD4 T cells and its application in adoptive T cell therapy

Project summary/abstract
Recent advances in adoptive T-cell therapy (ACT), especially CD19-targeting chimeric antigen
receptor (CAR) T-cell therapy (CD19CART), have highlighted the potential of immunotherapy to
achieve durable and curative patient outcomes. However, even for the well-developed
CD19CART, many patients have failed to respond to the treatment or succumbed to late relapse.
Moreover, so far ACT in general has not been effective in treating most solid tumors. The major
barriers to effective ACT include deficiencies in donor T cell expansion, persistence and tumor-
infiltration, as well as loss of T-cell effector function - a process termed exhaustion. There is
increasing demand for novel strategies that can overcome these barriers to improve the efficacy
of ACT. The presence of CD4 T cells with a polyfunctional phenotype, characterized by
concomitant production of multiple inflammatory cytokines, has been associated with favorable
therapeutic outcomes in preclinical models and cancer patients. However, how to generate
polyfunctional CD4 (pfCD4) T cells suitable for ACT remains elusive. We previously reported that
CD4 T cells exposed to interleukin 7 (IL7) during antigenic stimulation can acquire
polyfunctionality in a STAT5-dependent manner. Our recent work demonstrated that ectopic
expression of a constitutively active form of STAT5 (CASTAT5) in CD4 T cells induces genome-
wide transcriptional and epigenetic remodeling in tumor-specific CD4 T cells, endowing these
cells polyfunctionality, exhaustion-resistance and tumor-infiltrating capability. Importantly,
CASTAT5 can markedly improve the expansion and persistence of CD19CAR T cells, resulting
in high cure rate in mice with advanced lymphoma. These new findings form the basis of our
central hypothesis that CASTAT5-induced epigenetic remodeling endows CD4 T cells
polyfunctionality and exhaustion-resistance, and these features equip CD4 T cells with superior
helper activities to orchestrate potent antitumor immune responses. This cross-disciplinary multi-
PI project will employ our well-characterized ACT model systems in conjunction with cutting-edge
epigenomics and single cell RNA sequencing technologies to advance our understanding of the
ontogeny, heterogeneity, regulatory circuitry and mechanism of action of pfCD4 T cells.
Specifically, we will investigate how persistent STAT5 signaling induces and maintains pfCD4 T
cells (Aim 1), how CASTAT5-induced pfCD4 T cells potentiate ACT (Aim 2), and the potential
utility of CASTAT5 in human CD19CAR T cells (Aim 3). Successful completion of this project will
establish CASTAT5 as a clinically applicable strategy to overcome the barriers impeding effective
ACT including CAR T cell therapy.

Public health relevance
Project Narrative The STAT5 signaling pathway is critical for T cell expansion, persistence, and function. The proposed research will characterize the transcriptomic and epigenetic features of antitumor CD4 T cells expressing a constitutively active form of STAT5 and establish the therapeutic utility of these genetically modified CD4 T cells in the context of adoptive T-cell therapy including the use of T cells expressing chimeric antigen receptors (CAR).